Identification of the factors underlying tooth field size and competency

PROJECT SUMMARY (See instructions):
RELEVANCE (See instructions):
PROJECT/PERFORMANCE SITE(S) (if additional space is needed, use Project/Performance Site Format Page)
Project/Performance Site Primary Location
Organizational Name:
DUNS:
Street 1: Street 2:
City: County: State:
Province: Country: Zip/Postal Code:
Project/Performance Site Congressional Districts:
Additional Project/Performance Site Location
Organizational Name:
DUNS:
Street 1: Street 2:
City: County: State:
Province: Country: Zip/Postal Code:
Project/Performance Site Congressional Districts:
PHS 398 (5HY$SSURYHG7KURXJK) OMB No. 0925-0001
Page 2 Form Page 2
Square, Tyler A
The overall dental morphology of an adult vertebrate is set in motion by the initiation of tooth fields at
specific regions in the body plan during early development. Thereafter, primary teeth form sequentially,
expanding each tooth field as new teeth are added at the tooth field margin. Basic research into the genes
and signaling pathways underlying these processes will reveal which cell types and genetic signatures are
associated with tooth field initiation and expansion, thus informing future attempts to create and
successfully implant live teeth. By determining which cell types are capable of undergoing transformation
to a dental fate, new avenues for the creation of lab-made tooth organs will be revealed. Additionally,
identifying the genetic signatures associated with tooth field expansion and arrest will provide information
about the greater context under which dental arcade expansion is facilitated. The present study will use a
newly developed set of stable transgenic stickleback fish and zebrafish to identify the cell types, transcript
profiles, and signaling events that underlie the processes of tooth field initiation, expansion, and arrest.
These model fishes present a unique opportunity to understand tooth field morphogenesis, because tooth
field position and size can be manipulated using genetic tools. In response to Eda overexpression, both
species form ectopic tooth fields in highly consistent locations in or on the head, while also expanding
endogenous tooth fields. By contrast, Dkk2 overexpression in stickleback reduces tooth field size by
inhibiting tooth field expansion. Aim 1 seeks to understand the gene expression dynamics of the switch to
a tooth organ fate by assessing the fine spatial expression patterns of genes encoding Tumor Necrosis
Factor Receptors (TNFRs), candidate receptors that may confer the response to Eda, and performing
single-cell RNA sequencing on tooth-competent regions microdissected from Eda overexpressing and WT
sticklebacks. Aim 2 of this project seeks to find gene expression differences associated with regenerative
vs non-regenerative teeth. Aim 3 will elucidate which developmental pathways are associated with tooth
field size and tooth row number by comparing the gene expression profiles of the dissected tooth field
margins derived from expanded (Eda overexpression), arrested (Dkk2 overexpression), and normal
stickleback tooth fields. Overall, these experiments will yield information on how teeth can be specified
(Aim 1) or regenerated (Aim 2), and which gene expression responses are concomitant with favorable or